Progressive Post-Stroke Cognitive Impairment: Mechanisms & Intervention

Post-stroke cognitive impairment (PSCI) is a leading VCID with no treatments. While it is known that proper
cerebrovascular function is critical for brain health, our poor understanding of the cellular/molecular mechanisms
that promote the onset and progression of cognitive decline at the vascular unit (VU)/neuron interface limited
the identification of therapeutic targets. Inadequate inclusion of vascular risk factors, biological sex and long-
term stroke care practices into the recovery research prevented the development of comprehensive preventive
and therapeutic strategies for PSCI. The goal of this proposal is to address these gaps in knowledge by
advancing our understanding of the role of the endothelin (ET) system beyond its extensively studied contractile
effects to the regulation of the VU (endothelial cell-pericyte-astrocyte) integrity using preclinical models of
hypertension, PSCI and rehabilitation. Brain ET-1 levels correlate with the degree of hypoperfusion and the
severity of dementia. Yet, how and to what extent the ET system contributes to PSCI is not known. In contrast
to the detrimental effects of ETA receptor (ETAR) signaling, the encouraging results of a recently completed
Phase III trial showed that the stimulation of ETBR improves functional outcomes. We have evidence that
prevention of cognitive decline is associated with preserved VU integrity; integration of enriched care (EnCare)
with social/physical activities to our stroke care paradigm attenuates PSCI in male SHRs; this is associated with
the prevention of stroke-induced increases in the expression of VU ETAR, brain microvascular endothelial cells
(BMVECs), which were previously thought to have only ETBR, also possess ETAR, and ETAR signaling
promotes BMVEC and pericyte degeneration (senescence, endothelial mesenchymal transition-EndMT, and
transition of pericytes to a microglia-like phenotype). We hypothesize that dysregulation of microvascular
ETAR/ETBR balance contributes to profound progressive PSCI in hypertension by promoting degeneration of
the VU which disrupts vaso-neuronal coupling. A corollary to this hypothesis is that modulation of the ET
signaling via ETAR blockade or ETBR stimulation will improve the functional and structural integrity of the VU
and prevent PSCI. Aim 1 will determine the relationship of post-stroke changes in the ET system with the
development of PSCI. Mechanistic Aim 2 will determine endothelial yin-yang (ETAR-ETBR) mechanisms
contributing to the regulation of VU phenotypes and vasotrophic (un)coupling by defining the impact of
modulation of the ETAR or ETBR signaling on autocrine/paracrine regulation of senescence and phenotypes of
VU cells in and targeted eETAR silencing on VU integrity and PSCI. Translational Aim 3 will determine the most
effective approaches to stimulate protective ETR signaling by defining the impact of intranasal or systemic
administration of ETAR antagonist BQ123 or ETBR agonist IRL-1620 alone and in combination with EnCare on
the development and progression of cognitive and psychological deficits and fluid/imaging biomarkers in PSCI.

Public health relevance
PROJECT NARRATIVE Vascular cognitive impairment/ dementia (VCID) occurs in up to 48% of stroke patients but has no FDA-approved treatment. Our research shows that VCID accumulates slowly after an experimental stroke and is preventable. With further research into the mechanisms and targets for intervention, this work has the potential to reduce the incidence of the second most common cause of dementia, VCID.